Cis-interaction mediated CD28 costimulation

Project Summary
Engagement of CD28 provides a critical costimulatory signal for T cell activation. Absence of adequate CD28
costimulation is a common feature of dysfunctional T cells in cancer and viral infections. However, although
augmentation of CD28 signaling is well known to be essential for restoring dysfunctional T cells protective
immune responses upon immune checkpoint blockade treatment, it is unclear how CD28 in those T cells is
activated in the absence of corresponding ligands on cancer and virus-infected cells, indicating the limited
mechanistic understanding of the B7:CD28 pathway. My preliminary data have suggested a novel mechanism
of CD28 activation by B7 on the same T cell (cis-B7:CD28 interactions), different from the known CD28
engagement by B7 on antigen-presenting cells (trans-B7:CD28 interactions). This finding has begun to reveal a
unique avenue to trigger CD28 signaling in effector T cells for vigorous anti-tumor and ant-virus immune
responses. Based on this finding, the objective of this K99/R00 application is to understand the function and
mechanism of cis-B7:CD28 interaction and leverage cis-activation of CD28 to enhance the activity of T cells
against cancer and infection. To this end, I propose the following aims: Aim 1: Establish a role of B7:CD28 cis-
interactions in regulating T cells activity. Aim 2: Dissect the molecular mechanism through which CD28 is
activated by B7 ligands in cis. Aim 3: Identify the function of cis-B7:CD28 interaction in T cell immune response
against tumor and viral infection. These three aims will allow me to perform a comprehensive investigation on
cis-B7:CD28 interactions and the knowledge gained from this study will likely provide valuable therapeutic
implications in CD28 targeted T cell therapy. I have a strong background in studying cis-interactions and their
functions in regulating T cell activity, which is evidenced by publishing two impactful papers during my
postdoctoral training. Importantly, I have established a series of unique and robust approaches to convincingly
decouple cis- and trans-interactions in coreceptors signaling. This has been the solid foundation of my proposed
experiments. Moreover, my mentorship committee and I have developed an individualized research training and
career development plan, which helps me obtain additional skillsets and expertise and ultimately ensures my
success in seeking an independent investigator position. University of California, San Diego provides the best
possible environment for my K99 research, including world-leading research, cutting-edge facilities and
extensive career development resources. Overall, this K99/R00 award will fulfill my career goal to understand
the function and mechanism of costimulatory receptor signaling in regulation of T cell activity and promote my
career transition into an independent investigator.

Public health relevance
Project Narrative The ability of T cells to destroy target cells (e.g., virus infected cells and tumor cells) critically depends on the CD28 costimulatory receptor, but the mechanism by which CD28 is activated in peripheral tissues is unknown since target cells do not display CD28 ligands. Guided by my preliminary data, this proposal aims to dissect a novel cell-intrinsic mechanism of CD28 cis-activation by its ligands expressed on T cells. Execution of the proposed research will define a new dimension of CD28 co-stimulation, and likely reveal innovative means for improving T cell based therapies against cancer and infectious diseases.